Core 1: Integrated Pathology and Radiology Core (iPRC)

PROJECT SUMMARY
The Integrated Pathology Radiology Core (iPRC) of the UW Prostate Cancer SPORE is dedicated to providing
expert and reliable pathology and imaging services to enhance translational prostate cancer (PC) research. The
theme of this core is to provide our UW Prostate Cancer SPORE investigators with a wide range of integrated
and coordinated pathology and radiology services including high quality and extensively annotated
biospecimens, state-of-the-art pathology, and advanced radiology imaging. The iPRC will provide services and
infrastructure to allow for reliable, reproducible, and high-quality pathology data to be linked with radiologic
imaging tumor identification and lesion-to-lesion correlation. This will integrate pathology-radiology data and be
linked to comprehensive clinical information as well as tumor-specific bioinformatics. The mission of the iPRC is
to provide the type and quality of services that will enable Prostate Cancer SPORE investigators to address
pathology, radiology, and quantitative imaging translational aims as well as generate reliable and clinically
significant findings that will impact treatment outcomes. Successful accomplishment of many of the translational
aims of the Prostate Cancer SPORE projects is dependent on the iPRC services. The specific aims of the iPRC
are strategically designed to produce a core service unique from existing cancer center cores that will directly
meet the needs of the Prostate Cancer SPORE projects and build a sustainable central organizing force for
future translational PC research. The unique infrastructure and resources created to support the UW Prostate
Cancer SPORE projects will provide an integrated pathology and radiology database repository to benefit
collaborative translational PC research projects at UW and the wider PC research community.